Proinflammatory properties of Paneth cells in intestinal inflammation

PROJECT SUMMARY
Crohn's disease, a chronic inflammatory condition that most commonly affects the ileum, has an unclear but
multifactorial etiology. The TnfΔARE/+ mouse model recapitulates features of ileal Crohn's disease and is driven
by systemic overexpression of TNF, a proinflammatory cytokine that is elevated in Crohn's disease patients. The
contribution of intestinal epithelial cell types to chronic, TNF-induced ileal inflammation is not known. Paneth
cells are a type of intestinal epithelial cell that secrete antimicrobials to protect the epithelium from microbes that
colonize the luminal compartment. It is hypothesized that impaired antimicrobial barrier function, due to Paneth
cell defects and loss, contributes to the development of Crohn's disease. However, our preliminary data suggests
that Paneth cells may have proinflammatory properties in chronic ileal inflammation, as Paneth cell ablation
reverses ileal disease in TnfΔARE/+ mice. The hypothesis of this proposal is that Paneth cells have proinflammatory
properties that drive ileal inflammation in the TnfΔARE/+ mouse model of Crohn's disease. Programmed cell death
and autophagy are tightly regulated cellular processes that allow the tissue to manage aged or stressed cells.
Although there is evidence that these processes may be dysregulated in Crohn's disease, there is no mechanistic
evidence of proinflammatory Paneth cell death as a driver of chronic ileal inflammation. In Aim 1, single-cell
technologies will be leveraged to investigate how specific mechanisms of Paneth cell death contribute to ileal
inflammation the TnfΔARE/+ model. Experimental approaches include advanced Paneth cell ablation techniques,
our multiplex immunofluorescence (MxIF) imaging pipeline, and transmission electron microscopy. Furthermore,
mesenchymal cells, such as fibroblasts, are in close proximity to Paneth cells and epithelial-mesenchymal
crosstalk is an established phenomenon in the intestine. Paneth cells express cytokines, such as TNF and IL-
17, and moreover, myofibroblasts are activated by epithelial-derived cytokines to promote an inflammatory
cascade. However, Paneth cell-derived factors, such as cytokines, have not been associated with Crohn's
disease, and furthermore, Paneth cell-mesenchymal cell interactions have not been established. In Aim 2, single-
cell techniques will be leveraged to identify Paneth cell-derived proinflammatory cytokines, and computational
methods will be used to determine if Paneth cell-mesenchymal cell interactions promote ileal inflammation. My
approaches include single-cell RNA-sequencing, our computational cell-cell communication pipeline, and our
MxIF imaging pipeline. I will also use mouse models to drive TNF overexpression from Paneth cells, and use in
vitro approaches to determine whether Paneth cell-derived TNF directly activates fibroblasts. Revealing
mechanisms by which Paneth cells drive ileal inflammation is critical for understanding Crohn's disease and will
lead to novel therapeutic targets.

Public health relevance
PROJECT NARRATIVE Paneth cells are implicated in the pathogenesis of Crohn's disease, but mechanisms by which they promote intestinal inflammation are unclear. Experimental and computational approaches and mouse models of Crohn's disease will be used to test the hypothesis that Paneth cells have proinflammatory properties that drive ileal inflammation in the TnfΔARE/+ mouse model of Crohn's disease. Understanding the mechanisms by which Paneth cells contribute to intestinal inflammation will shed light on the pathogenesis of Crohn's disease and will facilitate the development of novel cell-type specific therapeutic strategies.